Heart disease &postprandial lipemia--Effects of a high fat vs. low fat diet

Participants in this study may have increased levels of fat in their blood. The consumption of dietary fat causes the level of fat (triglyceride) in the blood to increase. It is hypothesized that a high fat diet may promote the development of atherosclerosis ("hardening of the arteries") in part because of the associated post-meal rise in the blood fat level. In this study, the investigators will compare the atherogenicity (capacity to cause atherosclerosis) of fat particles isolated from blood after high fat and low fat test meals.